Contrasting biotic and abiotic drivers of adaptive evolution in a host-pathogen conflict

Project Summary/Abstract
To be successful, organisms must adapt to both abiotic (e.g. environmental pressures) as well as biotic
(e.g. parasites) selection pressures. Although both of these pressures can drive evolutionary innovation, theory
predicts that antagonistic relationships may drive recurrent episodes of adaptation. Dissecting these selective
pressures has implications for understanding treatment of both human infectious disease and cancers, where
both pathogens and clonally dividing malignant cells are adapting to both host immunity (biotic) and
environmental (abiotic) therapeutics. Additionally, the human microbiota is a complex and dynamic community
containing competing microbes in the context of both host immunity and gut environment. These complex co-
evolution scenarios are challenging to study and disentangling the respective contributions of various selective
pressures and fitness tradeoffs can be confounding. I propose to use RNA viruses of yeast as a model system
to study the evolutionary consequences of both abiotic and biotic selective pressures of genome evolution in
the presence of genetic conflict. RNA viruses of yeasts encode a “Killer” toxin-antitoxin addiction system, which
protects virus-bearing Killer cells but kills virus-lacking sensitive cells. As a result, these RNA viruses can be
maintained in host populations despite imposing a metabolic cost to their host. In my research proposal, I will
study adaptation in the face of both abiotic (toxin) and biotic (virus) selective pressures. Killer itself
requires multiple viral genomes for toxin production as well as host cellular components. With sensitive cells in
the environment, this system is a four-party genetic conflict, with competing fitness tradeoffs. In spite of this
complexity, budding yeast is one of the best-supported model eukaryote systems with many genetic and
molecular tools. This makes this model system supremely experimentally tractable, even while maintaining the
biological complexity of a naturally occurring system.
I will identify beneficial mutations that arise in populations of competing killer and sensitive cells (Aim
1), in sensitive cells that evolve resistance to toxins in the absence of virus (Aim 2), and determine which
genomes adapt to regain competitive fitness in a molecular arms race (Aim 3). Together, these aims will
uncover how intricate biotic systems co-evolve and constrain one another and reveal the evolutionary
dynamics imposed by antagonistic coevolution, versus abiotic adaptation. Understanding how genomes
evolve, and specifically how genetic conflict (antagonistic co-evolution) drives adaptation, is fundamental for
understanding and treating many processes that shape and drive disease. By exploring host-parasite
coevolution from first principles, we can develop a foundation towards understanding the impact of these
processes on human health and disease. This proposed work will benefit many fields by experimentally
addressing fundamental questions about how biotic and abiotic selection drives and constrains evolutionary
outcomes.

Public health relevance
Narrative Viruses, and other genetic parasites such as transposons, shape the evolution of their hosts, while host immunity drives viral evolution: together this creates biological innovation and adaptation, but with sometimes unforeseen or complex tradeoffs, such as increasing the prevalence of alleles that are detrimental under other circumstances. The human genome is no exception, with ~40% of the genome largely comprised of selfish elements such as transposons, and novel viral threats emerging to challenge host innate and acquired immunity. This proposed research will leverage a naturally occurring, but experimentally tractable, model system to dissect competing biotic and abiotic drivers of host and genetic parasite evolution, as well as complex fitness tradeoffs, to study the fundamental basis of how parasites shape genomes and host adaptation.